Chemogenetic stimulation of sympathetic preganglionic neurons and serotonergic reorganization after spinal cord injury

Project Summary/Abstract
This proposal aims to characterize the potential beneficial effect of focal chemogenetic stimulation of sympathetic
preganglionic neurons in the recovery of sympathetic regulation of blood pressure after left surgical hemisection
in the rat. Spinal cord injury (SCI) can cause serious cardiovascular dysfunction. One of the most common
dysfunctions is orthostatic hypotension, which is the inability to achieve an upright posture without fainting.
Sympathetic regulation of blood pressure is driven by preganglionic neurons located in the lateral horn of the
thoracic and upper lumbar spinal cord. Orthostatic hypotension after SCI is caused by a loss of supraspinal
regulation of spinal sympathetic preganglionic neurons. Considering that the most significant rate of
improvement in motor function occurs within the first six months after the SCI, after which progress plateaus,
early and effective physical therapy is imperative. As such, orthostatic intolerance is a significant barrier for
those with SCI to participate fully in rehabilitation, thereby impeding recovery. We have previously mapped the
spinal pathways in the rat responsible for baroreflex-mediated activation of sympathetic preganglionic neurons
to regulate blood pressure. We observed that over eight weeks, rats recover some degree of baroreflex function
after severe SCI as long as some baroreflex-related spinal pathway is spared. This recovery is likely due to an
increased efficacy of the remaining spinal pathways after the injury. Considering that approaches for the repair
and/or regeneration after SCI have been elusive, this discovery provides an opportunity to determine the
mechanistic action in the neuroplasticity after SCI for improving sympathetic regulation of blood pressure.
Advances in rehabilitation, particularly spinal cord stimulation, have improved sympathetic regulation of blood
pressure. While the mechanism of action is not fully known, animal models suggest that plasticity is due to
engaging previously dormant neural tissue. However, it is unknown if it activates sympathetic preganglionic
neurons directly or indirectly via stimulation of spinal networks that synapse on sympathetic preganglionic
neurons. This is important because a better understanding of the neural mechanisms will provide better-
targeted therapeutics. We propose using a novel targeted chemogenetic approach in transgenic rats to
exclusively stimulate only sympathetic postganglionic neurons independent of the surrounding spinal network.
In doing so, we will determine if chronic focal stimulation of sympathetic preganglionic neurons after SCI
improves the recovery of sympathetic baroreflex function. We will also determine if this stimulation improves
the reorganization of spinal networks involved in the sympathetic regulation of blood pressure. Thus, the goal
of this small research project is to provide proof of concept for a novel approach to stimulate sympathetic neurons
after SCI. This project will provide a data-derived path for more extensive studies to better understand the
regulation of sympathetic activity and neuroplasticity, improve blood pressure regulation, and ultimately improve
the ability to participate in rehabilitation after SCI.

Public health relevance
Project Narrative Spinal cord injury (SCI) can seriously impair the ability to regulate blood pressure, which poses a significant obstacle to participation in rehabilitation. While modest recovery may occur over time, the most significant motor recovery occurs within the first six months. This small research project aims to provide proof in concept for targeted focal stimulation of the neurons that control blood pressure in augmenting the recovery of cardiovascular function after SCI and the cellular changes within the spinal cord.